CORE--EXTERNAL INNOVATIVE NETWORK

The External Innovative Network Core brings together small teams of investigators to work in collaboration with one another on complex areas of inquiry. Some of these projects are cross-national and involve the co laborative engagement of investigators from multiple countries. In these projects, the laim is to address a common issue, while learning from the diverse policies, institutions and experience of ithese different countries. The cross-national projects are often organized around a set of parallel investigations in each country, enabling more meaningful comparisons across countries. Other projects focus on issues in aging in the United States where a multi-faceted investigation can be fruitful. For these projects, each member of the collaborative group looks at a different but related aspect of the broader subject.